A Turn-Key Single Molecule Localization Microscope for Imaging Extracellular Vesicles and Nanoparticles

SUMMARY
We request funds to purchase an ONI Nanoimager super-resolution microscope to support cutting-edge NIH-
funded extracellular vesicle (EV) and nanoparticle research at Vanderbilt University (VU) and Vanderbilt
University Medical Center (VUMC). The ONI Nanoimager is a class 1 laser, four-color fluorescence super-
resolution microscope that provides a user-friendly solution for resolving nanoscale structures at 20 nm
resolution. Its patented vibration-dampening microscope body can be placed on a standard lab desktop and
yet generate single molecule localization data. The Nanoimager was developed with state-of-the-art
characterization of EVs, nanoparticles, and other nanoscale structures in mind. It performs single-molecule
localization microscopy (SMLM) modalities, including dSTORM, PALM, and PAINT, and is uniquely capable of
super-resolution single-molecule FRET and single particle tracking. It further surpasses the function of other
shared super-resolution microscopes at Vanderbilt by performing simultaneous two channel imaging and has a
superior 100X magnification,1.45 numerical aperture objective. The light engine is equipped with 405 nm, 488
nm, 560 nm, and 640 nm high-powered lasers and a dichroic mirror split at 640 nm. Users can adjust the
illumination angle in 0.5 degree increments for imaging in epifluorescence, HILO, and TIRF modes. The
accessory environmental chamber allows extended live cell imaging under physiologically supportive
conditions, while the APLO Flow microfluidic device provides our EV research users with end-to-end
automation, from EV capture to labeling to imaging, and the capacity to perform microfluidics-based
experiments. Operation of the Nanoimager is remarkably simple, with many customizable pre-built imaging
protocols and powerful data analysis tools available. These attributes are quite unusual for a super-resolution
microscope, making it ideally suited as a Core instrument. Our Major and Minor Users will use the
Nanoimager’s super-resolution imaging capabilities to study diverse biological processes in cell and cancer
biology, including immunology, neurobiology, drug delivery design, and biomarker studies. Major users'
projects focus on EV and nanoparticle biogenesis and composition (Pua, Weaver, Coffey, Wilson), disease
biomarkers (DelGiorno), EV functions in extracellular matrix organization (Weaver), and EV and nanoparticle
immunopotentiation and suppression (Coffey, Wilson). The Vanderbilt Cell Imaging Shared Resource (CISR)
and the Vanderbilt Center for EV Research will promote the utility of the Nanoimager to VU and VUMC
researchers through seminars, workshops, and website content. CISR will administrate scheduling, train users
in the operation of the instrument, manage use, and apply an established business model to support the long-
term maintenance of the system. In summary, the ONI Nanoimager will permit multiple modes of high-speed
super-resolution imaging and single particle analysis designed to support cutting-edge EV and nanoparticle
research not currently available to the Vanderbilt community in a compact and user-friendly format.

Public health relevance
NARRATIVE The ONI Nanoimager is a turn-key, benchtop super-resolution fluorescence microscope, with unique single molecule localization capabilities for resolving and analyzing the individual cargoes of nanoscale extracellular vesicles and nanoparticles, as well as fine cellular structures. There is a substantial need for the Nanoimager to support the cutting-edge, ongoing work of numerous NIH-funded investigators in the Center for Extracellular Vesicle Research and other Vanderbilt research communities in the areas of cancer, neurodegenerative disease, immune disorders, viruses, and other human health problems. Significant resources from the VU School of Medicine are pledged to ensure its successful implementation.